Michigan Vision Clinician Scientist Development Program

ABSTRACT
The Michigan Vision Clinician-Scientist Development Program is a proven mechanism for growing the number
and effectiveness of clinician-scientists in vision research. It is based on an interdisciplinary approach
leveraging collaboration across the University of Michigan. The Program encompasses the full range of
scientific inquiry from basic discovery science to clinical trials to health services and is dedicated to providing
early- career investigators the resources to develop research programs addressing the NEI mission and
strategic plan. It is designed around best practices, with individualized, multidisciplinary, and dedicated
mentoring teams for each scholar with a focus on continuous improvement and productivity. This approach
will produce vision clinician-scientists who can successfully translate cutting edge scientific advances into
enhanced patient treatment by advancing our understanding of the visual system and patient well-being in
both health and disease. We propose to maintain two scholars at a time who will also have considerable
departmental support until they achieve independent-researcher status. The impact of the Program will be
measured by the scientific achievements of the scholars and their career trajectory and success in
establishing independent contributions and programs.

Public health relevance
PROJECT NARRATIVE The Michigan Vision Clinician-Scientist Development Program develops ophthalmologists who can further our understanding of vision and its preservation. This mentored research training program provides the foundational resources for scholars to build their research programs and mature into independent investigators who will contribute to new knowledge and therapies and inspire future young clinicians, researchers, and clinician-scientists.